E-TREAT: Evaluation of Telemedicine for diabetes care in Latinos

PROJECT SUMMARY
E-TREAT: Evaluation of Telemedicine for diabetes and hypertension care in Latinos
Latinos are more likely to have diabetes and hypertension and to face poor outcomes and complications from
these diseases. Quality primary care can reduce poor outcomes from these diseases, but primary care
services changed drastically in 2020 because of the COVID-19 pandemic. The pandemic shifted many primary
care visits from face-to-face visits to telemedicine (telephone and video) visits. It is uncertain how frequently
Latino patients with diabetes and hypertension utilized (and continue to utilize) these types of visits, and how
this may have affected the services they received for diabetes and hypertension, and how well their diseases
were controlled. It is also unknown how various social factors (community economic resources, language
barriers, access to broadband internet) might moderate the association of telemedicine on diabetes and
hypertension care and control. This study will assess the use of telemedicine (video and telephone visits) vs. in
person visits between Latino and non-Hispanic white patients with diabetes and/or hypertension seen at
community health centers in the United States over the course of and subsequent to the COVID-19 pandemic.
It will also assess the association of telemedicine utilization with the receipt of recommended diabetes and
hypertension care services, and assess the potential of social determinants of health to moderate the
effectiveness of telemedicine in mitigating disparities in diabetes and hypertension care between Latino
populations and non-Hispanic white populations in these patients. Understanding the quality of diabetes and
hypertension care delivered via telemedicine among Latinos with diabetes and hypertension and which social
determinants of health moderate its effectiveness is critical for healthcare planning and policies around
reimbursement and regulations and will have a significant impact on patients, clinicians, policy-makers, and
healthcare system leaders and allow for equitable healthcare delivery.

Public health relevance
PROJECT NARRATIVE Latinos are more likely to have diabetes and hypertension and to face poor outcomes and complications from these diseases. The COVID-19 pandemic has shifted many primary care visits from face-to-face visits to telemedicine (telephone and video) visits, and it is uncertain how frequently Latino patients with diabetes and hypertension utilized (and continue to utilize) these types of visits, and how this may have affected the services they received for diabetes and hypertension. This project will use a highly innovative electronic health record database that contains telemedicine and in-person visit data to understand the quality of diabetes and hypertension care delivered via telemedicine among Latinos.